Evolution of germline/soma distinctions across the eukaryotic tree of life

? DESCRIPTION (provided by applicant): Genomes are generally viewed as static, at least throughout the life cycle of any particular species. Yet evidence from lineages across the eukaryotic tree of life indicates that genomes can be dynamic. Evidence of genome dynamics includes varying levels of DNA (i.e. ploidy levels), amplification of specific regions of the genome, and chromosomal rearrangements analogous to those found in human immune cells. These data suggest that eukaryotes may have the ability to distinguish between the DNA that they will pass on to future generations from other genetic material that is more malleable. In some lineages, like animals, there is a physical separation between germline and somatic genomes. In other eukaryotes, it is possible that epigenetic marks such as chromatin modification play a role in distinguishing germline from somatic material. The proposed work will test three interrelated hypotheses on the nature of eukaryotic genomes by 1) reconstructing the evolutionary history of genes involved in marking genomes; 2) elucidating specific mechanisms used to distinguish germline and somatic genomes in the ciliate C. uncinata; and 3) collecting next generation sequence data from a variety of ciliates to enable comparative analyses in this ~1 billion year old clade. Data will be collected using a modified phylogenomic pipeline and high throughput sequencing of both populations and single cells. Hypotheses will be analyzed using both bioinformatics and population genetic tools (e.g. maximum likelihood analyses of gene gains/losses and patterns of substitutions). The proposed work will take place at Smith College, an all women's predominantly undergraduate institution. Each year, undergraduates will participate directly in the research and learn about the results in one of the courses taught by the PI. This project will also enable training of a graduate student participating through the Organismic and Evolutionary Biology Program at UMass-Amherst. 1

Public health relevance
PUBLIC HEALTH RELEVANCE: Microbial organisms provide model systems to explore genome processes and historically have provided insights that are relevant to human health (e.g. discovery of self-splicing introns and telomeres in ciliates). The proposed work, which focuses on the differences between germline and somatic genomes across the eukaryotic tree of life, may provide insights into the changes in somatic genomes that are associated with aging and disease (i.e. some cancers) in human cells. Hence, the data on the molecular evolution of germline/soma distinctions elucidated in this study will increase our understanding of genome changes that impact human health.